Co-Parenting Dynamics and Early Childhood Obesity

ABSTRACT
This supplement will support the training and mentorship of Ms. Carmen Ramos, MS RD, a US
Citizen and Latina woman raised in a low-income household. Ms. Ramos is pursuing a PhD at
the University of Michigan School of Public Health. Her career goal is to become an NIH-
supported investigator conducting research to identify social and behavioral approaches to
prevent nutrition-related chronic diseases among marginalized communities. The objective of
Ms. Ramos' proposed research is to identify how two aspects of coparenting, general
coparenting and child feeding-specific coparenting, relate to children's eating, activity, and sleep
home environments, and obesity risk, among participants in the parent study, Maternal Self-
Regulation and Early Childhood Obesity. Family systems research has long understood that
how parents coparent, that is, how they relate to one another in their parental roles, impacts
child socioemotional and behavioral development. Meanwhile, the influence of coparenting on
children's eating, activity, sleep, and weight is poorly understood. The specific aims of this
supplement are to, 1) Identify relationships between parents' general coparenting quality;
families' eating, activity, and sleep home environment; and young children's adiposity; 2)
Identify relationships between parents' child feeding-specific coparenting quality, families' eating
home environment, and young children's adiposity; and 3) Examine the intersection of general
coparenting and child feeding-specific coparenting including whether combinations of these
constructs are differentially associated with families' eating home environment and young
children's adiposity. The foundational research proposed in this supplement will help achieve
the goal of the parent study to improve childhood obesity prevention and treatment by
identifying aspects of coparenting that are critical to address to support sustained changes in
families. Award of supplemental funding to support Ms. Ramos will advance her scientific
knowledge, improve the quality of our research, and contribute to the NIH's goals of developing
high-quality scientific human capital.

Public health relevance
PROJECT NARRATIVE This supplement will support Ms. Carmen Ramos' training and mentorship, accelerating her trajectory toward becoming a PhD-level Latina nutrition scientist. This study will elucidate how coparenting dynamics may influence the home environment and children's risk for obesity across diverse family structures.